"Bridges to the Baccalaureate Research Training Program at LaGuardia Community College"

Project Summary/Abstract
LaGuardia Community College’s “Bridges to the Baccalaureate Research Training Program” has
demonstrated high graduation and high transfer rates for our students, conclusively
demonstrating that a community college can take the lead in administering a successful Bridges
program. Our program has formed a consortium with three exceptional four-year colleges—the
City College of New York, Hunter College, and Queens College—to provide challenging research
experiences in the biomedical and behavioral sciences for our underrepresented college students:
women, minorities, the disabled, and those from economically disadvantaged backgrounds.
LaGuardia proposes to place 10 students in hands-on, mentored research experiences each year
of the grant period. These students will choose from a list of research projects and will be engaged
in preliminary, preparatory research at LaGuardia, under the tutelage of the LaGuardia Faculty
Research Mentors. This experience gained will then be utilized during the summer, as the Bridges
students become involved in more intensive research at our three linking colleges, Brookhaven
National Laboratories, and SUNY downstate Medical Center.
The Bridges program also features a number of activities designed to support the students:
monthly research student seminars, tutoring, transfer counseling, opportunities to present their
research results at local and national conferences, instruction in the Responsible Conduct of
Research, Rigor and Reproducibility, instructional workshops on bio-statistics, leadership and
self-management skills, bioinstrumentation, research paper critique, library research, research
design, data science, introduction to Python, and poster presentation and the use of ePortfolios.
The ePortfolio will be used by Bridges students to collect their academic work, progress report
and to reflect on their learning and career goals. The program will also offer LaGuardia faculty the
opportunity to participate in effective mentoring workshop offered at the university of Wisconsin
and Bridges students will also enroll in the National Research Mentoring Network (NRMN).
The monthly research seminars are notable in that they feature progress reports and formal final
reports by the students themselves, presentations by CUNY faculty and outside speakers,
information from the program’s transfer counselor, a session on developing and delivering
professional presentations using PowerPoint, and an Alumni Homecoming Day where Bridges
alumni return to share their successes and research with current Bridges students. Bridges
students will also use an adapted version of myIDP (Individual Development Plan) to explore
careers in biomedical, sciences, and bioengineering.

Public health relevance
Project Narrative LaGuardia Community College’s “Bridges to the Baccalaureate Program” provides mentored research experiences year round to qualified minority, economically disadvantaged or disabled students. Beyond the research experience, the program features instructional workshops on quantitative literacy (Biostatistics), oral presentation, research paper critiques, bio- instrumentations, research design, data science, mentoring, leadership and management skills, monthly research student seminars, tutoring, transfer and transfer counseling, student presentations at local and national conferences, instruction in Responsible Conduct of Research, Rigor and Reproducibility and the use of e-Portfolios.